Effectively Linking Molecular Informatics and Network Analytics to Reduce Malaria (ELIMINAR-Malaria)

Understanding human mobility is critical to achieving malaria elimination. This is particularly important in regions
such as the Amazon, which has the goal of eliminating malaria by 2030, and where declining incidence rates are
leading cases to become increasingly clustered into networks of villages that are connected due to human
mobility and other environmental factors. These networks and villages are therefore at risk of malaria importation.
However, efforts to understand how human mobility contributes to importation and diffusion are either incomplete
or ill-suited to the Amazon context. For example, while mobile phone data have been used to track mobility in a
number of settings, coverage is nonexistent in the rural Amazon, and is otherwise unable to capture the many
different reasons people travel. Other approaches in the region have leveraged GPS tracking or individual-level,
participatory mapping approaches, which cannot be easily scaled to collect data across an entire region to
identify metacommunities or quantify mobility within and between them. Moreover, none of these approaches
are able to track parasite populations. However, the molecular studies that do so are either cost-prohibitive or
have insufficient coverage of the malaria genome to inform about importation in increasingly low transmission
settings. Finally, all of these studies ignore the crucial role that community network ties have on human mobility
and, by extension, malaria parasite structure and importation. Therefore, the objective of this proposal is to
effectively link scalable and actionable network and molecular tools to understand the ways in which human
mobility contributes to malaria population structure, importation, and diffusion in the northern Peruvian Amazon.
Aim 1 of this proposal focuses on collecting primary community network data to: 1) quantify human mobility
patterns, including drivers of mobility and seasonal variability, 2) identify networks of villages based on mobility
patterns, and 3) quantify the effects of mobility on malaria transmission. Aim 2 will link these community network
data with genomic surveillance of malaria parasites to: 1) identify how network structure contributes to malaria
population structure, and 2) identify source and sink communities of malaria transmission, and 3) quantify the
effect of different types of human mobility on malaria importation both between villages and between networks
of villages. The overarching hypothesis is that network structure is a fundamental driver of malaria population
structure, while human mobility within and between networks drives importation and diffusion. This proposal will
make significant contributions to ongoing malaria surveillance and control in the region, and be conducted in
collaboration with Peru’s Malaria Zero program, which his tasked with eliminating malaria in the region.

Public health relevance
Project Narrative Malaria kills over 600,000 people every year, and causes hundreds of millions of additional infections that impose significant financial burdens on the individuals infected, their families, their communities, and the health system. The Amazon region aims to eliminate the disease by 2030, but there are important gaps in our understanding of malaria epidemiology that will prevent successful elimination. The objective of this proposal is to address one of those gaps: how human mobility contributes to malaria population structure, importation, and diffusion, and do so by leveraging data fusion to effectively link efficient, cost-effective survey and genotyping methods.